ASSESSING THE EVIDENCE: HOME VISITING EVIDENCE OF EFFECTIVENESS

The Home Visiting Evidence of Effectiveness project (HomVEE), is a transparent, systematic review of the evidence base for multiple home visiting programs for pregnant women and young children birth to age 5. The project, conducted through a contract to Mathematica Policy Research, aims to improve knowledge about overall efficacy, efficacy by outcomes, information on subgroup populations, and implementation of home visiting models. The project conducts a comprehensive review of the evidence of effectiveness of home visiting program models that support children's health and development, school readiness, reductions in maltreatment, positive parenting practices, and improved family self-sufficiency (when in conjunction with child outcomes). Users can access the site at: http://homvee.acf.hhs.gov/.